Statistical and Deep Generative Modeling for Enhanced CyTOF Data Interpretation and Discovery

Project Summary
Background: Proteomics and genomics researchers have developed two distinct single-cell profiling
technologies: mass cytometry (CyTOF) and single cell RNA sequencing (scRNA-seq). These technologies hold
great promise for unraveling cellular heterogeneity, developmental trajectories, cell-cell interactions, and disease
physiology. CyTOF directly measures proteins, providing more immediate insights into cellular functions and
disease physiology than scRNA-seq. However, analysis methods for CyTOF lag significantly behind those for
scRNA-seq. This proposal addresses three critical gaps in developing innovative, user-friendly, and well-
validated CyTOF analytical tools. (1) Current CyTOF methods lack a coherent framework to handle multiple
tasks seamlessly. Sequential analysis pipelines relying on diverse task-specific models may hinder consistency
and interpretability, with neglected task interdependence and uncertainties from earlier steps leading to error
accumulation. (2) While scRNA-seq and CyTOF data integration offers significant advantages, an integrated
approach that utilizes prior biological knowledge from multiple sources for cross-modality learning is urgently
needed to simultaneously perform essential single-cell analysis tasks. (3) The lack of a reliable Imaging Mass
Cytometry (IMC) data simulator, which is crucial for thorough testing and objective benchmarking, has impeded
the development of robust IMC methods.
Overall methodology: We will leverage statistical and deep generative modeling to develop computational
methods for integrated and integrative CyTOF analyses and IMC data simulation. A team of experts in Bayesian
modeling & computing, scRNA-seq/CyTOF, optimization & structure learning, imaging analysis, and
environmental health, has been formed. Our recent publications in Nature Methods, Nature Communications,
Cancer Discovery, Annals of Applied Statistics, Biostatistics, and Bioinformatics demonstrate our strong
expertise and resources in fields relevant for this study. Aim 1 introduces cytoONE, a scalable, interpretable,
and integrated approach that employs both Bayesian hierarchical modeling and deep generative modeling to
simultaneously perform common CyTOF analysis tasks. Aim 2 is to develop CySCI, a semi-supervised diagonal
integration method, enabling joint analysis of CyTOF and scRNA-seq data. CySCI introduces a novel graph
attention network with added regularization to incorporate biological information from different sources,
facilitating cross-modality learning for dimension reduction and cell typing while performing cell abundance
differential analysis via an integrated Bayesian approach. Aim 3 devises IC-Sim, the first IMC data simulator
based on a sophisticated statistical model using Markov Random Fields. Software tools for cytoONE, CySCI and
IC-Sim will be developed and applied to data from our collaborators, generating findings for their ongoing studies.
Expected impact: The proposed project is expected to significantly enrich the toolset of CyTOF researchers,
unlocking the full potential of CyTOF and revolutionizing how researchers perceive and understand CyTOF data.

Public health relevance
Project Narrative In recent years, mass cytometry (CyTOF) has witnessed exponential growth in its application, enabling the characterization of proteomic profiles in a vast number of heterogeneous cells and providing insights beyond single-cell RNA-sequencing (scRNA-seq). However, the development of CyTOF analysis methods lags behind scRNA-seq, and applying scRNA-seq methods to CyTOF data often results in poor performance or even outright failure, due to their distinct natures. This proposal leverages statistical and deep generative modeling to develop advanced methods for integrated and integrative CyTOF data analyses and Imaging Mass Cytometry data simulation, which, coupled with user-friendly software, will propel the molecular characterization of single cells, and enhance our understanding of how single-cell phenotypes contribute to disease physiology.